Development of first-in-class antagonists of the retinoid pathway as novel oral immunotherapies for solid cancers

Project Summary:
The majority of cancer deaths are caused by dissemination and growth of secondary tumors throughout
the body. While the 5-year survival rate for localized cancers has dramatically improved over the last
four decades of drug development, the survival rates for cancer patients with advanced or metastatic
disease remains abysmal, with median survival of Stage 4 patients at 10 months following diagnosis.
Patients diagnosed with advanced or metastatic cancers are furthermore considered terminal as
metastatic lesions are resistant to current therapeutic options. New therapeutic agents that can
effectively treat and enforce regression of advanced cancers or established metastases are urgently
needed in the therapeutic repertoire, yet only immune checkpoint blockade therapies have shown the
ability to prolong survival in a small subset of patients with Stage 4 cancer. Therefore, immunotherapies
with novel mechanisms of action and complementarity to current therapies are urgently needed to
increase the percentage of responding patients and improve cancer survival metrics in the United
States. Our academic collaborators as well as other leading academic laboratories have identified an
immunosuppressive signaling pathway driven by two complementary enzymes that is critical to the
progression of solid tumors by generating an immunosuppressive tumor microenvironment. Both our
discovery work and recently published studies demonstrate this pathway is a critical node in the
progression of multiple cancer types such as sarcoma, melanoma and breast cancer, yet prior
commercial and academic attempts to drug this pathway have failed due to lack of potency, specificity
and/or poor pharmacological properties. We are the first group to have developed lead compounds
against this pathway that show exceptional potency and specificity while avoiding the pharmacologic
liabilities of other drug development programs. Importantly, our therapies show promise in treating
advanced and metastatic cancers and are characterized by low nanomolar potency (<50 nM, a 100-fold
improvement over published molecules), no off-target activity, high metabolic stability, excellent oral
pharmacokinetic properties and promising in vivo toxicology. Here we propose to nominate a
development candidate through pharmacodynamic assays, dose-range finding studies and
immunocompetent cancer models. The results of this research proposal will advance a first-in-class
therapy toward clinical testing with the aim of curing patients who were once diagnosed as incurable.
Specifically, the efficacy and preclinical data obtained from this application will support Phase 2 SBIR
studies leading to an IND application.

Public health relevance
Project Narrative: This project advances a novel immunotherapy with both potent single agent activity and exceptional combinatorial activity that has the potential to enforce durable remissions in patients with advanced or metastatic solid cancers. Kayothera has developed this first-in-class therapy using a next-generation drug discovery platform in order to target an immunosuppressive signaling pathway critical to the survival of solid cancers. Specific aims outlined in the grant will provide the basis for advancing this therapy to IND-enabling experiments through a series of pharmacokinetic and pharmacodynamic assays.